IGF::OT::IGF - SUPPORT SERVICES FOR EPIDEMIOLOGY - TASK ORDER 8 - "AGRICULTURAL HEALTH STUDY"

The purpose of this Task Order is to conduct case validations under the existing framework of the health follow-up protocol for case validation and cohort-wide follow ups to update health status with the AHS cohort. Under this Task Order, the Contractor will develop materials for ascertaining health status and conduct cohort-wide follow ups in selected samples of the cohort.